ANG1-7 as an intervention for Alzheimer's Disease.

PROJECT SUMMARY
The objective of this study is to evaluate the impact of orally delivering Lactobacillus paracasei genetically
modified to express Angiotensin (1-7) (LP-A) on Alzheimer’s Disease (AD). Aim 1 will test the hypothesis that
LP-A treatment at the onset of pathology will significantly slow or delay accumulation of pTau and Aβ, markers
of inflammation, loss of noradrenergic axons, and hippocampal synaptic dysfunction in TgF344-AD rats that is
dependent upon activation of Mas receptors. Aim 2 will test the hypothesis that LP-A treatment improves
performance in hippocampus-dependent behavioral assays and decreases anxiety in TgF344-AD rats that is
dependent upon activation of Mas receptors. ANTICIPATED IMPACT: To date, proven treatments for preventing
age- and AD mediated cognitive decline are lacking, thus research on potentially efficacious interventions is
desperately needed. This study holds tremendous potential for generating proof of concept data that an orally-
provided intervention improves or prevents deficits in synaptic circuit and cognitive function. The work is
significant because it addresses several clinical and public health problems deemed critical by the NIH.
Innovations in the project include the conceptual approach using genetic engineering techniques to deliver
therapeutic compounds in probiotic form, and the study design which lays the groundwork for future translation
to humans to ultimately help address the massive health burden of AD related cognitive decline.

Public health relevance
PROJECT NARRATIVE PUBLIC HEALTH RELEVANCE – Declines in cognitive function due to Alzheimer’s Disease threaten the independence and quality of life for many older adults. This project will provide valuable new information regarding a potential novel therapeutic strategy with strong potential for translation to humans. This approach targeting a highly-promising and underexplored area has important potential for improving late-life health.